Accelerated Aging as a Cause of Chronic Lung Allograft Dysfunction

Lung transplantation is a lifesaving option for veterans with end-stage lung diseases, in particular idiopathic
pulmonary fibrosis (IPF). Veterans appear to be disproportionately affected by IPF, a disease that has been
described as early aging of the lung. IPF is usually fatal unless the lungs are replaced by transplant. Even
following lung transplantation median survival is less than six years, limited primarily by chronic lung allograft
dysfunction (CLAD). Emerging data suggest that telomeres, the nucleoprotein caps that protect chromosomes
during cellular replication, are involved in IPF, but it is unknown whether telomeres also play a role in CLAD.
Were that to be the case, the same pathophysiology that necessitated transplant might also underlie its failure.
Our own preliminary data show that impaired telomeres in peripheral blood of lung allograft donors are linked
to decreased survival in lung allograft recipients. We also have found that telomere dysfunction in airway stem
cells is sufficient to induce the pathologic hallmarks of CLAD in an experimental murine model. In humans,
airway progenitor cells proliferate and differentiate to restore airway epithelial integrity following injury. Thus,
telomere dysfunction could lead to airway epithelial cell progenitor failure, resulting in denuded airways that
are subsequently replaced by fibrotic tissue. With the support of this Merit Award, we will test the innovative
hypothesis that telomere dysfunction leads to CLAD. In Study Aim 1, we will evaluate the associations
between telomere genetic variants and CLAD in a large established multi-center cohort of lung transplant
recipients. Common genetic variants resulting in short telomeres will be sequenced from donor cells, and
telomere length will be determined by quantitative PCR. We will use adjusted Cox proportional hazards
models to evaluate the links between donor telomere length or genotype and post-transplant survival time.
Novel genotypic associations with telomere dysfunction will be validated in vitro. These findings will help
distinguish the contributions of innate and acquired telomere dysfunction to poor post-transplant outcomes.
Study Aim 2 will test the association between short allograft epithelial cell telomeres and CLAD-free survival
in a longitudinal cohort. Epithelial telomere lengths will be determined by fluorescence-in situ hybridization
with a telomere-specific probe (Telo-FISH) on endobronchial and transbronchial biopsy tissues. We will test
the association between telomere length and CLAD-free survival using adjusted Cox models and examine
transcriptomic sequelae of telomere dysfunction. In Study Aim 3, we will determine whether airway epithelial
cell injury is associated with allograft telomere shortening and epigenetic aging in a prospectively enrolled
cohort of lung transplant recipients. Early allograft injury will be assessed clinically by the presence of primary
graft dysfunction (PGD). We also quantify allograft epithelial cell injury from recipient plasma cell-free DNA
using next-generation bisulfite sequencing to enumerate donor-specific polymorphisms and cell-type specific
DNA methylation patterns. We will test for associations between PGD and cell-free DNA measurements of
allograft injury with telomere-based and epigenetic metrics of allograft aging using adjusted linear models.
These findings will shed light on the longstanding question of how acute lung injury and inflammation develop
into chronic fibrosis. Further, these studies could establish that CLAD is an evoked phenotype in which
telomere dysfunction leads to impaired epithelial responses to chronic transplant-associated airway injury.
Overall, this proposed investigation has the potential to reshape our conceptual understanding of CLAD and
lead to novel biomarkers that could inform cutting edge therapeutic interventions. This would be new
paradigm, potentially transforming our approach CLAD and thus improving outcomes for veterans with end-
stage lung disease.

Public health relevance
This proposal tests the hypothesis that transplanted lungs fail because of telomere dysfunction acquired from the donor that results in rapid aging of the lung after being placed in the recipient. Lung transplantation is a vital treatment for idiopathic pulmonary fibrosis (IPF), which has increased prevalence among veterans. Assessment of donor telomere dysfunction could inform risk assessment for lung transplant for candidates. Telomere shortening, when present in airways, could be both an early mechanistic biomarker for studies of peri-operative interventions and could identify recipients who could benefit from therapies to augment airway regeneration. Further, common genetic variants that evoke an early aging phenotype following transplantation could play a role in other fibrotic lung diseases. Finally, development of technologies to quantify organ aging and identify the cellular origin of plasma cell-free DNA could lead to rapid diagnostics for a variety of diseases, from IPF to neurodegenerative diseases.